CLINICAL IMMUNE SURVEY OF THE LONGITUDINAL PROJECT PARTICIPANTS

These studies utilize participants in the Baltimore Longitudinal Study of Aging to gain insight into the genetic, biochemical and molecular mechanisms underlying age-associated changes in immune function. The projects are directed toward distinguishing and characterizing the origins of defective T cell activation and proliferation.